Imaging of glutamatergic system changes in Alzheimer's disease in vivo

Abstract
Alzheimer’s disease (AD) is the most common form of dementia in the elderly and the sixth leading cause
of death in the US. Over 25 million people are affected by the disease and as the aging population increases,
this number is expected to double by 2025. Characteristics of AD include progressive memory loss, decline in
cognitive skills, and adverse behavioral changes. The hallmark brain neuropathologies of AD include the
accumulation of extracellular amyloid-b (Ab) plaques, intracellular neurofibrillary tangles (NFTs) formed by
aggregates of all 6 tau isoforms, early synaptotoxicity and neurotransmitter alterations, gliosis, and ultimately
neuronal loss and brain atrophy. Since there is currently no disease modifying treatment for AD, there remains
a pressing need for development of therapies that can stop or slow its progression. However, research to develop
and evaluate novel AD therapies is hampered by an incomplete understanding of the precise etiology of the
disease and a lack of imaging biomarkers sensitive to specific pre-symptomatic molecular changes underlying
AD onset and progression that are translatable to human studies.
Emerging data suggests that early cognitive changes in AD may be due to the dysregulation of excitatory
glutamatergic neurotransmission by soluble Ab oligomers, which lead to tau phosphorylation, over stimulation of
glutamate receptors and synaptic alterations. Oligomeric Ab also impairs the normal function of astrocytes,
thereby contributing to glutamate-mediated neuronal excitotoxicity and eventually to neurodegeneration in AD.
Since, synapse loss is the best correlate of memory deficits in AD, Ab plaques and/or NFTs may not capture
earliest changes that contribute to the initiating stages of AD. Accumulating data suggest that changes in
glutamatergic system function can potentially serve as a target for further mechanistic insights of AD and for the
development of both early biomarkers as well as disease modifying therapies for AD.
Changes in glutamate (Glu) and myo-inositol (MI) observable noninvasively using magnetic resonance
imaging methods, may serve as surrogate biomarkers to probe dysregulation of the glutamatergic system due
to changes in synaptic density and astrocytic density, respectively. Although, 1H magnetic resonance
spectroscopy (MRS) is the standard approach for measuring these metabolites, it has lower spatial resolution
than magnetic resonance imaging (MRI).
In this proposal, we will further develop and optimize recently introduced chemical exchange saturation
transfer (CEST) weighted imaging methods for measuring glutamate (GluCEST) and myo-inositol (MICEST) that
out-perform 1HMRS in terms of sensitivity and hence spatial resolution in measuring glutamate and myo-inositol,
respectively. Specifically, we will first establish the precision and specificity of the methods in measuring the
glutamate and myo-inositol in AD pathology. Then, we will perform CEST MRI in AD mouse models (APP-KI,
AD-APP-KI) that closely recapitulate human AD, as a function of disease onset and progression, and determine
the association of changes in these indices with the changes in the immunohistochemistry (IHC) derived
measures of synaptic and astrocytic density. Successful completion of the proposed project will lead to: (i)
mechanistic information about critical role that glutamatergic system plays in the initiating stages of the disease
and progression (ii) validated and clinically translatable noninvasive imaging biomarkers that measure disease
at the pre-symptomatic stages and follow it longitudinally (iii) noninvasive biomarkers that can be used to identify
disease targets and longitudinally evaluate potential disease modifying therapies and thereby contribute to the
enhanced patient care.

Public health relevance
Narrative: In this proposal, noninvasive imaging biomarkers of glutamatergic system changes in Alzheimer's disease (AD) pathology are developed and evaluated. Specifically, magnetic resonance imaging biomarkers of synapse loss and changes in astrocytic density will be evaluated longitudinally in mouse models that recapitulate the human AD. Results from this work will contribute to the mechanistic understanding of the AD onset and progression and lead to validated and clinically translatable biomarkers that can facilitate the development and evaluation of the efficacy of disease modifying therapies and thereby contribute to enhanced diagnosis and management of patients in the AD spectrum.